Ontology-based aPplications of mUlti-discipLinary knowlEdge on orodeNtal Conditions and outcomEs (OPULENCE)

PROJECT SUMMARY/ABSTRACT
Orodental sequalae after radiation therapy (RT) for head and neck cancer (HNC) pose a significant problem for
survivors, their oncology and dental providers, and the healthcare system. A recent prospective trial using
advanced RT techniques and comprehensive pre-therapy dental evaluations found that within 2 years of finishing
RT, 18% of patients suffered tooth loss, dose-dependent gingival recession with increased post-radiation caries
(PRC) risk was frequently observed, and 6.4% developed bone exposure or osteoradionecrosis (ORN). These
orodental toxicities result in diminishing quality of life, especially ORN which is associated with high symptom
burden (i.e., dentition and activity limitations) and high financial costs. The combination of a lack of standards for
reporting oncologic orodental sequalae, interoperability limitations between electronic medical and dental record
systems, and poorly understood biological mechanisms of orodental disease, result in uncoordinated and
information-deprived care. Clinically, there exists a knowledge gap on how to conceptualize and report the
presence and/or severity of diseases such as ORN which has over 16 published staging systems, or PRC which
is often measured using the Post-Radiation-Caries Index or International Caries Detected and Assessment
System, both of which underestimate rates of PRC. Moreover, no consensus on assessing or reporting post-RT
POD exists. The OPULENCE multi-institutional and multidisciplinary investigative team has started to bridge
these unmet needs through published clinical standards for pre- and post-RT assessments and procedures, the
development of clinical and image data-driven models for ORN, and contributions to the first publicly available
operational ontology for oncology (i.e., for data harmonization and computable knowledge of general cancer
care). Furthermore, we have published findings from a small prospective study which showed significant oral
microbial shifts and reduced activation of oral neutrophils, changes that correlate with oral inflammation and
POD, a known independent risk factor for ORN. Through the OPULENCE Proposal, we aim to open new horizons
for early orodental disease diagnosis, toxicity mitigation, and data-driven management by leveraging artificial
intelligence/machine learning methods for multi-domain ontology learning with corresponding common data
elements highly expressive of the full (clinical, imaging, and biologic) spectrum of orodental disease (Aim 1),
facilitating multidimensional, image-based FAIR data generation and application through informatics models of
2D-3D image transformation and NTCP models of PRC and POD (Aim 2), and prospectively identifying deep
phenotypes and performing causal analysis on the interplay between biomarkers and post-RT orodental
complications (Aim 3). All aims are highly synergistic with NIDCR future research initiative interests including
investigations of personalized dental treatment practice prior to cancer therapy, developing risk assessment
algorithms for early toxicity detection, monitoring and treating orodental complications, and enabling meaningful
oncologic (i.e., medical) and dental care coordination.

Public health relevance
PROJECT NARRATIVE Radiation therapy (RT) for head and neck cancer (HNC), while often curative, can induce or worsen orodental diseases such as periodontal disease (POD), post-radiation caries (PRC), and osteoradionecrosis (ORN). Early diagnosis, multidisciplinary communication, and data-driven management of these conditions is severely hindered by a lack of standards and a fragmented research landscape with large knowledge gaps arising from siloed data that is not readily findable, accessible, interoperable, or reusable. The OPULENCE Proposal aims to address these unmet clinical needs by developing AI-augmented innovative orodental ontological systems with corresponding common data elements implemented in a prospective study, informatics models for multidimensional image data transformation, and deep phenotyping of high-risk survivors through the development and validation of biology-driven models that assess the oral microbiome and oral immune domains as biomarkers for orodental disease risk.